Dissecting the Synaptic and Cellular Actions of Dopamine in Vivo - Diversity Supplement

Project Summary
Dopamine (DA) is a neuromodulator that is implicated in motivating, producing and reinforcing actions. Although
phasic increases and decreases in DA response to different stimuli have been extensively studied, our
understanding of their impact on downstream neural activity remains limited, constituting a major impediment to
the treatment of psychiatric disease. The parent R01 to this supplement is focused on understanding how
DA release influences the activity of these downstream neurons by measuring the effect of behaviorally
and optogenetically-evoked DA transients on D1- and D2-SPNs.
However, dopamine signaling occurs concomitantly with other neuromodulators that are also thought to
play key roles in these processes. The serotonin (5HT) system, in particular, projects to overlapping brain areas
and, together, the two neuromodulators are the target of many neuropsychiatric drugs. Like DA neurons, 5HT
neurons exhibit tonic firing at baseline and transiently increase or decrease their firing depending on behavioral
state changes or environmental stimuli. While both DA and 5HT have been implicated in reward processing, the
relationship of their activity during behavior remains largely unexplored. Defining distinct patterns of DA and 5HT
signaling during reward driven behaviors is a first crucial step toward understanding how these neuromodulators
act in concert to mediate behaviors associated with psychiatric disease states, such as depression and anxiety.
In this proposal, we seek to understand the dynamics between 5HT and DA during behavior, and how
these neuromodulators together influence the activity of downstream neurons. To do this, we will first
characterize 5HT and DA dynamics in the Nucleus Accumbens (NAc), leveraging recent methods that have been
developed to simultaneously record the release of these neuromodulators in behaving mice (Aim 1). Next, we
will image 5HT, DA, and neuron activity simultaneously to understand how the activity of these two
neuromodulators correlates with, and modulates neural activity in the NAc (Aim 2). Overall, we hypothesize
that DA and 5HT have stereotyped release dynamics relative to one another and that each
neuromodulator plays a distinct role in shaping activity of downstream neurons.

Public health relevance
Project Narrative Dopamine (DA) in a neuromodulator that is implicated in motivating, producing and reinforcing actions. Serotonin acts in concert with DA to drive behavior and regulate mood, although much less is known about this system. In this supplement, we aim to quantify of how these neuromodulators work together during learning and how this relates to the activity of downstream neurons, information that is crucial to understanding how drugs that target these systems exert their effects.